Prenatal alcohol exposure generates vulnerability to the proinflammatory effects of morphine and adverse neuroimmune consequences

PROJECT SUMMARY
Exposure to alcohol during gestation can lead to a constellation of mild to severe cognitive and behavioral
deficits referred to as Fetal Alcohol Spectrum Disorders (FASD), having a US prevalence as high as ~4.8%.
Although clinical studies on long-term consequences of prenatal alcohol exposure (PAE) are sparse, high
prevalence of substance use (e.g., alcohol, opioids) is observed in adult FASD populations which may stem
from aberrant neuroimmune interactions following exposure to alcohol or opioids. This proposal examines
whether PAE induces susceptibility to neuroimmune dysfunction following opioid pain therapy in animal
models. In PAE animal models, heightened production of proinflammatory cytokines including interleukin-1β
(IL-1β) in the adult central nervous system (CNS) is observed. Our recent work in animal models suggest that
PAE is a risk factor for developing CNS pathology such as pathological pain (allodynia) through the actions of
spinal astrocyte and macrophage activation by their release of IL-1β and tumor necrosis factor-α (TNF-α). A
critical innate immune receptor underlying increased IL-1β and TNF-α is Toll Like Receptor (TLR4), that upon
its activation, produces downstream NLRP3 inflammasome signaling and consequent IL-1β. Curiously,
morphine, a standard pain therapeutic acting on the μ-opioid receptor, also activates proinflammatory TLR4
signaling resulting in opponent processes; µ-opioid cellular actions to blunt pain and immune TLR4 cellular
actions that cause pain. Consequently, higher doses of morphine may be required to achieve pain alleviation in
some populations. Based on this background, we speculate that PAE may generate biological vulnerability to
CNS pathology by sensitizing TLR4 responses to endogenous factors and morphine that readily interact with
TLR4. Thus, one goal of this proposal is to identify if morphine treatment in mice unmasks the insidious effects
of PAE on neuroimmune function resulting in chronic CNS pathological consequences. Preliminary data show
morphine exposure paradoxically prolongs the course of allodynia in minor nerve-injured adult PAE mice. The
potential convergence of PAE and opioid-induced TLR4 actions is entirely unexplored. Therefore, our
hypothesis is: PAE primes the TLR4-NLRP3-IL-1β pathway that is unmasked by endogenous pain-enhancing
factors and morphine interacting with TLR4 resulting in chronic pathological neuroimmune function. The Aims
of the proposal will determine if : (I) PAE augments morphine-mediated TLR4 &/or NLRP3 activation in minor
nerve-injured mice causing prolonged allodynia, (II) PAE sensitizes the effects of morphine on TLR4/NLRP3
responses in spinal astrocytes and peripheral macrophages, and (III) the contribution of non-coding circ-Vopp1
dysregulation in PAE-primed TLR4 signaling in response to morphine. Results will provide new evidence for
PAE as a risk factor for adverse opioid responses and will identify novel targets to mitigate the risk of
neuroimmune dysfunction from adverse TLR4 actions in individuals with FASD.

Public health relevance
PROJECT NARRATIVE A substantial neuroimmune overlap exists between preclinical evidence of prenatal alcohol exposure (PAE) and opioid-mediated immune actions with convergence suspected to occur upon activation of the innate immune receptor, TLR4, resulting in proinflammatory cytokine and neurological dysfunction. A strikingly similar mechanism is observed from PAE-primed glial-immune actions from a minor nerve injury, supporting the application in this proposal of a mouse model of PAE to understand how exaggerated TLR4 activation is engaged following morphine exposure for treating pain that paradoxically prolongs pathological pain states such as allodynia. Identifying mechanisms underlying morphine’s proinflammatory effects worsening allodynia rather than suppressing it in PAE offspring is critical as clinical research suggests that individuals with a history of PAE are more likely to engage in substance use disorders, and a biological vulnerability to develop adverse neuroimmune interactions from opioids exposure may play a role, in part, to future opioid misuse.